Diet Related Inflammation and Kidney Function Decline in Racial/Ethnic Minorities

PROJECT SUMMARY/ ABSTRACT:
The primary purpose of this proposal is to provide Tanya Johns, MD, MHS, a clinical investigator in the
Department of Medicine (Division of Nephrology) at Albert Einstein College of Medicine/ Montefiore Medical
Center, with the skills and mentored guidance necessary to develop into an independent clinical researcher
and a nationally recognized expert focused on reducing health disparities in chronic kidney disease (CKD). Dr.
Johns’ research proposal examines the relationship between dietary patterns and inflammation, and its
association with kidney function decline in racial/ethnic minorities. Growing evidence suggests that pro-
inflammatory dietary patterns may adversely impact kidney health; but this has not been fully investigated,
especially in minority populations who bear an excess burden of CKD. Dr. Johns will leverage large, well-
established NIH funded cohorts of racial/ethnic minorities with longitudinal data to test the association of diet-
induced inflammation with kidney function decline. She will also examine the effects of the Multicultural Healthy
Diet (anti-inflammatory dietary pattern) intervention on CKD risk, and the feasibility in individuals with
established CKD. Specifically, she aims to: 1) characterize dietary patterns in community-dwelling African
Americans (n= 5,306) and Hispanics (n= 16,415) and its associations with systemic inflammation and kidney
function decline; 2) evaluate the effect of the Multicultural Healthy Dietary (MHD) intervention on CKD risk in an
ongoing clinical trial of older predominately racial/ethnic minority participants (n= 277); and 3) conduct a small
pilot study (n= 20) to evaluate the feasibility and acceptability of a MHD-like intervention in racial/ethnic
minorities with CKD. To successfully complete these research aims and transition to independence, Dr. Johns
has developed a comprehensive 3-year research program that includes: i) mentorship from a multidisciplinary
team with expertise in nutrition, longitudinal data analyses for cohort studies, clinical trials, comparative
effectiveness studies, and health disparities research; ii) completion of courses in nutritional epidemiology,
biostatistics, comparative effectiveness research, and clinical trials; iii) dissemination of her work through
presentations at national research meetings and publications in high impact journals; iv) grantsmanship
activities geared towards writing a competitive R01 by the end of her award period. Each member of Dr. Johns’
mentorship team has a long track record of successfully mentoring junior investigators, and is fully committed
to working together to help her achieve career benchmarks and attain research independence. The resources
at Albert Einstein provides an ideal environment in which to complete her training and research goals. With the
knowledge and expertise gained from her research and career development activities, Dr. Johns will be well
poised to evaluate novel risk factors for CKD, which will inform the development and implementation dietary or
other interventions to halt kidney disease initiation and progression in racial/ ethnic minorities. With this award,
Dr. Tanya Johns will be well prepared for a career as an independent clinical investigator. (30 lines; Limit 30
lines of text)

Public health relevance
PROJECT NARRATIVE This research proposal will improve our understanding of the relationship between dietary pattern and inflammation, and its impact on kidney function decline among racial/ethnic minorities. The results of these studies could inform novel dietary approaches to mitigate chronic kidney risk and progression, and address a major health disparity. At the end of this mentored research period, Dr. Johns will have developed the skills and expertise necessary to successfully transition into research independence with a focus on reducing health disparities in chronic kidney disease. (3 sentences; limit 3 sentences)